Sex and pubertal influences on developmental trajectories of brain networks involved in schizophrenia

Despite clear scientific and relevance to public health, the mechanisms underlying heterogeneity in schizophrenia
(SZ) are poorly understood. There is a critical need to identify mechanisms that contribute to heterogeneity as
current treatments are ineffective for the majority of patients. One source of heterogeneity is biological sex. Our
central hypothesis is that: (1) sex-differential symptoms in SZ arise from sex differences in specific neural
networks, and (2) these sex differences emerge as a consequence of pubertal influences during the critical
neurodevelopmental period of adolescence. The Adolescent Brain and Cognitive Development study (ABCD),
a 10-year longitudinal study following 11,875 9-10-year-olds into early adulthood, is uniquely capable of testing
this hypothesis. In response to this FOA, we propose to use ABCD baseline and follow up data years 1-6 to
examine sex and pubertal influences on adolescent development of two neural networks associated with sex
differences in SZ. We will assess task-based activation and connectivity in the frontal-limbic emotion regulation
and frontal-striatal reward processing networks using Emotional N-Back and Monetary Incentive Delay fMRI
task data respectively. We will also assess resting state functional connectivity (rsFC) in each network. We will
test sex and pubertal influences on activation and connectivity in each network at ABCD baseline (Aim 1), as
well as associations between sex, puberty, and developmental trajectories of each network (Aim 2), and the
development of psychosis, negative valence, and positive valence system symptoms (Aim 3) from baseline (9-
10 years old) to Year 6 (15-16 years old). We will pursue the following Specific Aims: 1. Characterize sex
differences and effects of puberty markers on frontal-limbic and frontal-striatal networks at baseline as
measured by task-based fMRI and rsFC. We hypothesize variability in puberty markers (development,
hormones) relates to variability in frontal-limbic and frontal-striatal networks and that sex moderates these
relationships. 2. Test effects of sex and puberty markers on age-related changes in frontal-limbic and
frontal-striatal networks as measured by task-based fMRI and rsFC at baseline, 2-, 4-, and 6-year follow
up. We hypothesize age-related changes in puberty markers mediate developmental trajectories of these
networks and that sex moderates these relationships. 3. Determine if sex and/or puberty markers moderate
activation and connectivity of each network at baseline, 2-, 4-, and 6-year follow up in relation to
development of psychosis and symptoms related to negative and positive valence systems in years 1-
6. We predict sex and puberty markers will covary with frontal-limbic and frontal-striatal networks over time to
predict subsequent development of sex-differential symptoms in SZ. This work will determine sex and pubertal
modifiers of neurodevelopmental trajectories that contribute to the emergence of SZ, a major NIMH priority.
Results will answer critical questions about mechanisms underlying heterogeneity in SZ and will have a
substantial public health impact by advancing new sex-based precision medicine treatments.

Public health relevance
Project narrative The proposed research is relevant to public health as it will advance new sex-based precision medicine treatments by answering critical questions regarding the contribution of biological sex to mechanisms underlying heterogeneity in schizophrenia. This project is relevant to NIMH’s mission to determine modifiers of maturational and illness trajectories during sensitive developmental periods (strategic objective 2.1), as it will determine sex and pubertal modifiers of neurodevelopmental trajectories that contribute to the emergence of schizophrenia.